Internalizing symptoms in adolescence: Understanding the roles of negative life events, emotion regulation, and the brain over time

PROJECT SUMMARY
Symptoms of depression and anxiety demonstrate a substantial increase in prevalence during adolescence and
high estimated comorbidity. The consequences of adolescent-onset internalizing disorder symptoms are
considerable, including an increased risk of suicide, which is already a leading cause of death for youth. Given
modest remission rates and treatment responses for both depressive and anxiety disorders, interventions based
on neurobiology and behavior during adolescence, a critical period of sustained neuroplasticity, may improve
early intervention efforts and minimize long-term harm. Research has aimed to elucidate adolescent-emergent
internalizing disorders by identifying brain biomarkers of transdiagnostic features, due to the overlap of many
depression- and anxiety-related psychiatric diagnoses. Dysfunctional emotion regulation (ER) is one such shared
feature, and literature has shown it is exacerbated by negative life events (NLEs), life changes that are
challenging (but not necessarily traumatic), particularly during adolescence when emotional reactivity is elevated.
NLEs are thought to promote emotion dysregulation and risk for internalizing disorders via prefrontal cortex and
amygdala development and connectivity disruption. Stress (broadly defined), internalizing pathology, and ER
dysfunction have also been linked to perturbations in resting state functional connectivity (rsFC) of brain networks
governing emotion-related higher-order cognition. While self-reported ER dysfunction has been shown to
partially mediate the NLEs-internalizing problem association in youth, more well-powered work is needed to
understand underlying neurobiological mechanisms, including whether changes in neural functioning provide
explanatory power and if neurobiological mediation persists over time. The goal of this study is to investigate
the extent to which ER trajectories, behaviorally and neurobiologically, mediate the relationship between NLEs
and changes in internalizing symptoms, while accounting for social risk and protective factors, in the large,
diverse Adolescent Brain Cognitive Development (ABCD) Study sample. Based on preliminary analyses, I
hypothesize that the trajectory of ER behavior and associated brain functioning will (1) at least partly mediate
the positive association between NLEs and internalizing symptoms over time; and (2) this mediation will be
stronger for those with low social support. Thus, this proposal aims to examine the trajectories of: (1) ER behavior,
(2) neural correlates of emotion-influenced cognition (as measured by Emotional N-back Task fMRI), and (3)
rsFC of emotion- and higher-order cognition-related brain networks as mediators of the link between NLEs and
internalizing symptoms across early adolescence, while evaluating social supports as moderators. Results from
this proposal may help to provide insights for more personalized treatments based on neurobiology, behavior,
and social context. Additionally, the robust and interdisciplinary training plan within a prominent academic
medical and research institution proposed in this application will allow me to establish a strong foundation for a
career as an academic physician-scientist at the intersection of psychiatry and translational neuroscience.

Public health relevance
PROJECT NARRATIVE Adolescent-onset internalizing disorders are a major public health concern and increase the risk of suicide, yet treatment efficacy remains low. The goal of the proposed research is to improve our understanding of how emotion regulation influences internalizing symptom trajectories during adolescence by examining the extent to which the trajectory of emotion regulation dysfunction-associated neurobiology and behavior mediates the association between negative life events—a risk factor for psychopathology defined as sudden, challenging life changes that are not necessarily traumatic—and internalizing symptoms using a longitudinal sample of nearly 12,000 youth. By elucidating how and to what extent emotion regulation dysfunction contributes to the association between negative life events and internalizing psychopathology during this critical developmental period, this work stands to improve the targeting, timing, and personalization of psychiatric prevention efforts and treatment for youth with depression and anxiety disorder symptoms.